21st Century Environmental Health Scholars: Increasing Diversity in Environmental Health Sciences Through Mentored Research Experiences (21EH Scholars)

PROJECT SUMMARY/ABSTRACT
The need for a diverse environmental health workforce has growing urgency as the population of
the planet nears eight billion people and the environmental health impacts of natural disasters
and drought become evident on every continent. In addition to understanding how environmental
stressors impact human health, scientists of the next generation will need to work across
disciplines to develop viable solutions to environmental and social challenges. Yet the disciplines
that underpin environmental health sciences—biomedical, clinical and behavioral sciences—lack
the diversity that bolsters effective problem solving (Ferrini-Mundy, 2013). More broadly, women,
persons with disabilities, and three racial and ethnic groups—people of African American,
Hispanic, and/or American Indian and Alaska Native descent—remain underrepresented in
science and engineering education programs and employment (NAS, 2011; NSF, 2019). Pursuit
of STEM careers requires additional support for all students, especially underrepresented minority
and women students who contend with systemic racial and gender bias. For these students, the
likelihood of persisting in STEM majors is influenced by opportunities to meaningfully participate
in the academic community and develop supportive relationships with faculty and peers (Figueroa
et al., 2015; PCAST, 2012; Tsui, 2007).
Within this context, the Curriculum in Toxicology & Environmental Medicine (CiTEM) in the UNC-
Chapel Hill School of Medicine, together with the UNC Institute for the Environment (UNC-IE) and
the Department of Biological and Biomedical Sciences at NC Central University (NCCU), propose
an environmental health-focused undergraduate research program to expand and diversify the
pool of students entering the environmental health workforce. The 21st Century Environmental
Health Scholars program will provide mentored research experiences and professional
development for students from diverse backgrounds, with a goal of preparing these students for
further studies or research careers in environmental health sciences. We will accomplish this goal
through the following aims.
Aim 1. Facilitate summer undergraduate research opportunities in environmental health
sciences.
Aim 2. Facilitate academic-year undergraduate research experiences and broaden
professional development to include environmental health sciences careers, science
communication, and community engagement.
Aim 3. Implement robust mentorship training that incorporates evidence-based practices in
mentoring diverse students and cohort building opportunities.
Over five years, this program will prepare 25 diverse undergraduates for careers in environmental
health sciences, introducing them to cutting-edge research topics and facilitating essential skills
development. At the same time, participating mentors will enhance their ability to create and
sustain inclusive learning environments. Together, these activities will encourage the participation
of individuals from diverse backgrounds to pursue environmental health sciences research and
careers.

Public health relevance
PROJECT NARRATIVE The overarching goal of 21EH Scholars is to expand and diversify the pool of students entering the environmental health sciences workforce. We propose to do accomplish this goal by providing summer and academic-year, mentored research experiences in environmental health sciences research labs at UNC-CH to students from diverse backgrounds including those who attend NCCU, a partner HBCU, and transfer students from the NC community college system. In addition to supporting the development of undergraduate researchers, the program also will provide professional development for students and robust mentorship training to prepare participating mentors to create inclusive learning environments.